Childhood Cancer Data Initiative

Childhood Cancer Data Initiative initiated studies: 1.A study on adolescent metastatic osteosarcoma was published in Cancer Research in which Spatial Profiling Identifies Regionally Distinct Microenvironments and Targetable Immunosuppressive Mechanisms in Pediatric Osteosarcoma Pulmonary Metastases. Data from this study was submitted to dbGaP study Accession phs003975.v1. 2. The study on pediatric and adrenocortical carcinoma was undertaken to understand the metastatic tumor microenvironmental landscape in pediatric and adult ACC using single-cell sequencing RNA sequencing from 28 tissue samples from 9 patients (1 pediatiric and 8 adults) with ACC. A manuscript is currently under-review. New Projects underway: 3. Project title: Single nuclei ATAC/RNA-seq of papillary thyroid carcinomas after the Chornobyl nuclear power plant accident The 1986 Chornobyl nuclear power plant accident released large amounts of radioactive fallout that was deposited in surrounding areas. One of the main adverse health effects of the accident was the increased risk of developing thyroid cancer among individuals who were exposed as children to radioactive iodine (131I), which concentrated in the thyroid following consumption of leafy greens and dairy products from animals that had grazed on contaminated pastures. We have completed genomic landscape profiling, including bulk mRNA-seq analysis, of 440 primary papillary thyroid carcinomas and 47 cervical lymph node metastases that were collected by the Chornobyl Tissue Bank. Ongoing analyses are investigating differentially expressed genes by cell type, open chromatin, and other metrics by radiation dose, PTC driver, and sample type, with the aim of providing further insights into radiation-related PTC carcinogenesis and the metastatic process. 4. Creating a neoplastic and immune cell atlas of pediatric brain tumors through spatial transcriptomic analysis In order to develop effective immunotherapies for brain tumor, a thorough understanding of the cellular landscape of pediatric brain tumors is necessary. In this study spatial transcriptomics of primary brain tumors of high-grade gliomas (HGG) and embryonal tumormultilayered rosettes (ETMR) and atypical teratoid rhabdoid tumors (AT/RT) will be performed in order to provide novel insights into the heterogeneity of cellular subpopulations and the interaction of neoplastic and immune populations within the TME. Spatial transcriptomics of 11 pediatric ETMR patient samples has been performed.